Administrative Core (AC)

PROJECT SUMMARY – ADMINISTRATIVE CORE
The Boston Health Equity & community-Aligned Learning Health System (Boston HEALHS) Administrative
Core (Admin Core) will provide the leadership to oversee, coordinate, and evaluate Learning Health System
(LHS) training and research within the BMCHS-BU academic-safety net health system. Guided by the
Consolidated Framework for Implementation Research, the Admin Core will ensure multi-directional
communication with internal and external stakeholders, promote participatory processes for decision-making,
and provide seamless management and coordination of activities though an organizational structure that
engages stakeholders with diverse perspectives. Leadership of the Admin Core will be from 3 MPIs, who
bridge leadership across BMCHS and BU with synergistic expertise in LHS Competencies, PCOR/CER, and
community engagement as well as expertise in leading training programs and large, administratively complex
projects, and mentoring diverse early career faculty. In partnership with hospital systems leadership, clinicians,
patients, community-based organizations, and LHS scientists, the Admin Core will lead an effective and
efficient governance structure of key stakeholders; oversee the implementation of equity-focused approaches
to recruit, retain, and foster the professional development of a diverse cadre of LHS scientists; implement a
process for selecting Patient Centered Outcomes Research/Comparative Effectiveness Research projects’
topical focus that elevates and integrates the priorities of community members, patients, clinicians and health
system leadership; and evaluate the impact of the Boston HEALHS program on individual scientists and
mentors, health system infrastructure and care delivery, using mixed methods to document key outcomes and
iteratively improve the program. Ultimately, the Admin Core will further develop and expand an innovative,
highly functioning LHS research infrastructure, training a cadre of scientists prepared to conduct rigorous
Patient Centered Outcomes Research/Comparative Effectiveness Research in partnership with the community
to improve outcomes for our country’s most marginalized patients.